Administrative Supplement to existing K08 award - K08DK120934-01-04 Van Batavia J - Role of CRH-neurons BN/Uncovering Heterogeneity of BN

PROJECT SUMMARY/ABSTRACT
The candidate for this K08 Mentored Clinical Scientist Research Career Development Award aims to become
an expert and leader in the field of neuro-urology, specifically on furthering our understanding of the brain-bladder
control of volitional voiding. Lower urinary tract symptoms (LUTS) and disorders of voiding are among the most
common reasons for referral to the urologist and affect ~20% of school-aged children and >40% of adults over
40 years old. Despite this prevalence, the specific neuronal populations that control voiding remain largely
unknown which limits therapeutic options. Recent advances in neuroscience, genomics and bioinformatics will
now allow study of specific neuronal subpopulations and characterization of the cellular heterogeneity inherent
to all brain and brainstem nuclei. The proposed research in this grant will be performed in primary mentor Dr.
Steven Zderic’s laboratory using mice. Aim 1 will determine the effects of long-term activation of one specific
neuronal subpopulation in the pontine micturition center (i.e., Barrington’s nucleus, BN) on voiding function.
These specific neurons express corticotropin-releasing hormone (CRH) and these neurons in preliminary studies
were shown to inhibit voiding, thus activation of these neurons is expected to cause infrequent voiding and lead
to bladder wall remodeling from chronic holding of urine. Aim 2 will identify the time and temporal pattern of
firing of these CRH-expressing BN neurons in relation to volitional voiding using fiber photometry in freely moving
mice. Aim 3 will utilize single cell RNA-sequencing techniques to identify and characterize the neuronal
subpopulations that reside in and around BN. The first two aims will help define the role of BN CRH-neurons
and potentially create a novel murine model of bladder wall remodeling, while aim 3 will lead to the identification
of novel neuronal subpopulations for future study which could potentially lead to new therapeutic targets for
LUTS and voiding disorders. The candidate brings to this proposal his experience studying voiding disorders
both from a clinical and basic science standpoint. This career development proposal aims to provide the
candidate with required additional training that leverages the resource-rich environment of the Children’s Hospital
of Philadelphia and University of Pennsylvania. The candidate will be guided by an experienced mentoring team
at CHOP [Dr. Zderic – Direct of Pediatric Urology Research; Dr. Seema Bhatnager – Associate Professor,
neuroscientist; and Dr. Deanne Taylor – Director of Bioinformatics]. An Advisory Committee of internationally
recognized leaders will provide content expertise and career counseling to ensure the candidate has a successful
transition to independence as a surgeon-scientist. All together this research and training plan will provide the
candidate with a foundation in advanced neuroscience, genomic, and bioinformatics necessary for achieving his
long-term goals of understanding how specific brain and brainstem neuronal populations control voiding and
finding ways to translate this knowledge into clinical improvement for patients with LUTS and voiding disorders.

Public health relevance
PROJECT NARRATIVE Lower urinary tract symptoms (LUTS) and the conditions (i.e., disorders of urination) underlying them affect ~20% of school-aged children and >40% of adults over 40 years old, yet our understanding of how the brain controls urination is limited. Our proposed research focuses on defining how specific types of nerves in the brainstem regulate this important biological function, specifically which nerves cause or prevent urination. Through these studies, we hope to identify new potential targets for novel therapies that can help both children and adults with disorders of urination.